Administrative Supplement for Equipment Purchase

PROJECT SUMMARY/ABSTRACT
Our parent grant focuses on the disruptions caused by trauma, infection, and sepsis that compromise immune
function. We have uncovered exciting new mechanisms that are essential for immune cell function and we
found that these important mechanisms are impaired in critically ill patients. We discovered that the functions
of immune cells depend on ATP release and autocrine feedback via purinergic receptors. We could show that
mitochondria deliver the ATP that drives these autocrine feedback mechanisms. For that purpose,
mitochondria are trafficked to specific regions within immune cells where they deliver their ATP in a
spatiotemporally highly organized manner. Our work has provided strong evidence that trauma, infection, and
sepsis impair these delicate signaling processes.
In order to study the rapid and complex signaling mechanisms associated with mitochondria and purinergic
receptor signaling, we must use live-cell imaging with a highly sophisticated microscope system. However, our
current microscope system is not fast and versatile enough to study the connections between the trafficking of
mitochondria, their activation, cellular ATP release, stimulation of purinergic receptors, and the function of
immune cells isolated from healthy subjects and critical care patients.
Here, we request supplemental funds that would allow addition of certain components to our existing
microscope system. These key components would greatly increase scanning speed and acquisition of confocal
images. The upgraded system would provide multi-dimensional data that would help to elucidate the central
roles of mitochondrial dynamics in the function of immune cells in health and disease.

Public health relevance
PROJECT NARRATIVE We found that mitochondrial dynamics regulate immune cells. In order to study if defects in mitochondrial dynamics cause immune dysfunction in critical care patients, we need the proposed upgrades for our live-cell imaging system.